Human_Animal_Imaging-Core

The Human and Animal Imaging Core (HAIC) provides access to state-of-the-art in vivo whole brain imaging technologies to DC-IDDRC investigators in order to support, facilitate, and enhance IDD-targeted research in humans and in animal models. To achieve the Core's aims we have established advanced imaging facilities at three collaborating DC-IDDRC institutions [Howard University (HU), Georgetown University (GU), and Children's National Health System (CNHS)] that provide structural and functional imaging of animal models and human populations. The HAIC provides access to a wide array of imaging tools to investigate mechanisms of disease, establish biomarkers, examine effects of disease, and monitor outcomes of interventions. We have made significant institutional investments in 3T human MRI scanners at CNHS that provide researchers with state-of-the-art imaging instrumentation and expand our imaging capacity in neonates and ill children. Furthermore, we now extend our capabilities with the addition of the preclinical animal imaging facilities, including 7.4 and 9T MRI scanners, at HU. To support this growth in the HAIC, a Co-Director with extensive animal imaging experience joins HAIC leadership. HAIC personnel provide technical expertise in imaging strategy design and essential imaging services, acquisition and innovative analysis methods across all sites and institutions. Core faculty and staff also help educate, train, and support investigators in the use of advanced neuroimaging methods, applications, and analysis software. The HAIC works synergistically, and fosters collaborations with other DC-IDDRC cores including the Neurobehavioral Evaluation, Genomics and Proteomics, Cell and Tissue Microscopy, and Clinical Translational Cores. Our administrative structure provides the quality control necessary for the integrity of a smoothly functioning core to achieve the DC-IDDRC mission.

Public health relevance
HUMAN AND ANIMAL IMAGING CORE: NARRATIVE The Human and Animal Imaging Core provides researchers of the DC-IDDRC access to state-of-the-art human and animal whole brain imaging technology and scanners. It provides maintenance of imaging equipment, provides technical support for data acquisition and analysis, develops approaches for optimal use of these technologies. Core personnel educates and trains researchers in appropriate use of these technologies and analysis of data gathered, in order to understand and to treat children’s diseases involving intellectual and developmental disabilities.! !